An initial test of biobehavioral mechanisms of sleep health alterations in the context of adolescent cannabis use using objective methods

Cannabis use (CU} is linked to sleep health domains. In adults, chronic CU has impacted sleep
architecture by decreasing REM and slow-wave sleep. There is a dearth of knowledge on adolescent CU
and sleep in general and from using objective sleep measures specifically, despite the endocannabinoid
system playing a role in both regulating sleep and facilitating adolescent brain development. The
dopaminergic system, substantially developing during adolescence and vulnerable to disruption by CU,
plays a critical role in reward, motivation, and arousal. Dopamine is a wake-promoting neurotransmitter
yet is also blunted by chronic CU. How neurobehavioral developmental changes during adolescence
associated with sleep impact problematic CU and exacerbation is unknown, curbing prevention and
intervention efforts. The research objectives of this proposal are to characterize sleep health processes in
adolescent CU using multimodal objective assessments. The central hypothesis is that CU during
adolescence is associated with altered neurobiology that influence sleep health processes and cannabis
use disorder (CUD} severity. The project will enroll 40 adolescents ages 14-15, half of whom have had at
least weekly CU for the past three months, who will undergo at baseline a sleep latency paradigm during
fMRI in which they will complete in random order a resting state MRI while awake, and while instructed to
try-to-sleep (TIS; 7 min each; within-subject) to characterize resting state network connectivity during
ITS. Another scan will obtain an indicator of mesolimbic dopamine neurophysiology. Next, adolescents
will start a 5-day assessment with at-home EEG and actigraphy devices. We will assess CU from 3
months pre-baseline through 3-months post-baseline, and CUD symptom severity will be measured at
baseline and 3-months. Aim 1 will identify how cannabis teens differ from controls on sleep architecture
and actigraphy-measured sleep indices. Aim 2 will test how brain connectivity indices during TTS differ
between controls and cannabis teens. Aim 3 will evaluate the link between mesolimbic tissue iron and
sleep health indices and describe how these differ for controls vs. cannabis teens. This proposal is
significant by addressing sleep health processes influencing the development and worsening of addiction
in the context of adolescent CU, and innovative by using objective sleep measures, an experimental sleep
paradigm during fMRI, and brain tissue iron measurements as an indicator of dopamine neurophysiology.